Role of mucin in lung homeostasis and pathophysiology

PROJECT SUMMARY
In many lung diseases--including asthma--excessive mucus disrupts clearance and obstructs airflow, but mucus
dysfunction is not effectively treated by existing therapies. The chief macromolecules in airway mucus are
MUC5AC and MUC5B. To study them causatively, we made Muc5ac and Muc5b knockout mice. We discovered
that Muc5b is required for mucociliary clearance (MCC) in health, but Muc5ac is dispensable. Instead, Muc5ac
causes mucus plugging and is required for airway hyperreactivity (AHR) in models of asthma. Nonetheless, despite
its homeostatic requirements in mice and humans, we now know that excessive MUC5B/Muc5b can itself be
detrimental in lung fibrosis (PF). These findings show significance, but they also highlight the need to find ways to
prevent mucus dysfunction while also preserving defense. We postulate that this can be accomplished in part
through an improved understanding of MUC5AC and MUC5B assembly mechanisms.
MUC5AC/Muc5ac and MUC5B/Muc5b are very large proteins that form even larger polymers via linkages
between their carboxyl (C-) and amino (N-) termini. Their pathologic properties depend on covalent disulfide bonds
whose reduction reverses AHR and improves MCC, suggesting that therapeutic intervention targets could be
revealed by determining precisely how mucins assemble. Mucin C- and N-terminal polymerization domains are
homologous with the protein von Willebrand Factor (VWF). Cysteines required for VWF assembly are conserved in
mucins. We have identified which are required for airway mucin assembly and function. Here we seek to continue
determine structural requirements and cellular mechanisms for mucin polymerization and function.
Emerging data suggest that a cluster of three cysteines referred to as a “cysteine triad” is crucial. One of
member of the triad is the cysteine that forms an inter-molecular disulfide. This requires the acidic environment
provided in the Golgi to facilitate disulfide exchanges that liberate cysteines needed for intermolecular disulfides.
Low pH also protonates histidines in domains that surround the triad. The cysteine triads and pH-sensing histidines
in VWF are conserved in mucins. We hypothesize that airway polymeric mucin biosynthesis is regulated by Golgi
specific mechanisms that mediate mucus function and dysfunction. We will test this by 1) examining how assembly
is regulated by Golgi-localized cysteine-triad dependent mechanisms, 2) determining the conserved histidine
residues are required for pH-dependent N-terminal assembly, and 3) demonstrating how these affect mucin
polymerization airway mucus functions. Studies here will advance the mucin biology field while laying groundwork
for approaches to prevent mucus dysfunction while preserving defense. While research here focuses on asthma,
results will have implications for diseases such as chronic obstructive pulmonary disease (COPD), CF, and other
conditions where mucus dysfunction is prevalent.

Public health relevance
PROJECT NARRATIVE (PUBLIC HEALTH RELEVANCE) Asthma is a common disease that has major impacts on human health, health care costs, and economic well- being. Airway passages are lined by a protective mucus barrier that becomes detrimental in asthma, resulting in impaired mucociliary clearance and disrupted breathing. Our research focuses on how specific proteins – MUC5AC and MUC5B – affect the functions of airway mucus in health and disease.